WASHINGTON UNIVERSITY SCHOOL OF MEDICINE UNDIAGNOSED DISEASES NETWORK CLINICAL SITE

PROJECT SUMMARY
Not applicable to this supplement.

Public health relevance
NARRATIVE Not applicable to this supplement.